Sensory and Motor Streams in Preclinical and Clinical Stages of Alzheimer's Disease

Project Summary (Abstract)
Alzheimer's disease (AD) causes alterations in sensory systems –such as olfaction or hearing-, and
motor domains that sometimes precede cognitive symptoms, as shown in longitudinal studies. However, it
remains largely unknown the specific role of sensory and motor disruptions within the AD neurodegeneration
process and its clinical use for predicting future dementia onset. In this proposal, we focus on the network
nature of sensory and motor changes in the aging brain. We postulate that AD neurodegeneration transversally
affects connectivity streams across neuronal systems involving multiple domains of network integration, from
sensory-motor to high-order cognitive brain centers. Thus, we will investigate the functional streams
connecting sensory and motor regions with associative cortex to disentangle the role of sensory-motor
disruption in the disease and its relationship with tau and amyloid accumulation at the brain circuit level.
Particularly, we will use functional connectivity MRI, multimodal PET neuroimaging (tau and amyloid tracers),
and graph theory metrics to reliably quantify the sensory and motor circuit changes in the cerebral tissue of
preclinical and clinical AD samples from our local Harvard Aging Brain Study at Massachusetts General
Hospital. Our preliminary data has demonstrated that network analysis can provide a highly accurate
quantitative map of the sensory-motor systems connectivity in aging populations, offering a firm basis for
assessment of AD related changes in brain function. In this multi-disciplinary investigation we will 1) quantify
sensory and motor functional streams in aging and AD (Aim 1); 2) investigate the association of sensory and
motor functional streams with tau and amyloid deposits (Aim 2); and 3) investigate the sensory and motor
connectivity changes in the follow-up (Aim 3).

Public health relevance
Project Narrative: This project focuses on a combined effort in which we will 1) investigate the sensory and motor streams in preclinical and clinical Alzheimer's disease (AD) cohorts using functional connectivity MRI and graph theory approaches; 2) analyze the cortical intersection between sensory and motor connectivity changes and tau and amyloid deposits in preclinical and clinical AD populations using multimodal PET neuroimaging; 3) characterize sensory and motor connectivity changes over time (from 2 to 4 years follow-up) and its associations with longitudinal variations in clinical, neuropsychological and PET profiles.